Number Doctors: The Emergence of Biostatistics and the Reformation of Modern Medicine

7. Project Summary/Abstract
Statistics fundamentally transformed the practice of and meaning of medicine in the twentieth century.
Though insurers and public health reformers had relied on actuarial and statistical calculations for
years, formal statistical tests and measures were rarely found in the medical literature in the 1930s. Just
a half century later, however, statistical calculations had become essential for clinicians and patients
seeking to measure the efficacy of new drugs, choose among treatment options, establish clinical
practice guidelines, recommend screening tests, or assess the carcinogenicity of everyday exposures.
Statistically-driven innovations such as randomized clinical trials, meta-analyses, n-of-1 and adaptive
trials, as well as prospective and retrospective studies have become central tools of modern medicine.
Yet we know surprisingly little about the emergence of biostatistics and the related field of clinical
epidemiology. Most existing histories of medicine have noted the rise of statistically-interpreted trials
as a strategy of physician-reformers looking to reduce the role of bias and subjectivity in medicine but
historians have yet to seriously engage with the technical transformations that enabled what was once
a field of averages and aggregation (and mainly of use to epidemiologists) to be applicable to decision
making at an individual (clinical) level. This transformation was controversial, and faced resistance
from many quarters, but particularly from surgical and other procedure-heavy specialties. This grant
will support production of a monograph, Number Doctors: The Emergence of Biostatistics and the
Reformation of Modern Medicine, that will reframe our understanding of how statistics and statisticians
came to play a transformative role in modern medicine. The monograph will partially center on a
group of biostatisticians hired in 1947 under sociologist Harold Dorn at the National Cancer Institute,
but that soon worked across the National Institutes of Health and other federal agencies, including the
Food and Drug Administration, Environmental Protection Agency, and Heath, Education, and Welfare.
Other chapters will trace the spread of statistical measures from population genetics and agriculture to
biostatistics and clinical epidemiology programs at universities as well as the development of
specialized journals and professional organizations. The final chapters will trace the origins of now-
common tools like metanalysis and simulation modeling. Drawing on archival materials as well as
accounts of medical reformers, the resulting monograph will be the first extended history of
biostatistics and clinical epidemiology, and will contribute to larger discussions about the role of data,
risk calculations, and the meaning of “evidence-based” and “precision” medicine.

Public health relevance
8. Project Narrative Going to the doctor has largely become an experience of risk calculation for patients, while for clinicians and researchers, the emergence of evidence-based medicine, as well as the more recent turn to precision and personalized medicine, are predicated on the ability to statistically process large quantities of medical data. This grant will support research for a monograph that transforms our understanding of the history of modern medicine by analyzing how statistical tools and concepts once understood as relevant only in aggregate, and for population-level analysis, came to be understood as relevant for making claims of causality and efficacy for individuals in the clinic. As the first book- length history of biostatistics and clinical epidemiology, this work will be of great interest to audiences in history of medicine, health policy, clinical medicine, epidemiology, and related medical social sciences, as well as to members of the lay public who find themselves curious about the central role of probability and statistics in medical treatment.